Translational Research Training in Child Psychiatry

PROJECT SUMMARY
This is an application for renewal of the T32, “Translational Research Training in Child Psychiatry” that has
been funded continuously since 1980. The mission of this program is to recruit and train the next generation of
translational scientists who recognize that the development of effective prevention and/or therapeutic
strategies for neurodevelopmental disorders requires studying the bidirectional pathways between the
underlying biology and environment at both the individual and population level. The success of the training
program is reflected in both the accomplishments of the trainees and in the diversity of the fellows.
In the past 15 years, 46 applicants were selected into the training program, of whom 74% were female and
33% were MDs (5 MD/PhDs and 10 MDs) and the remaining were PhDs. Over the past 15 years, our trainees
have received substantial independent funding including 14 career development awards (K08, K01, and K23),
19 R01-level grants (R01, SC1, UH3, UG3), 4 R21s, 2 R25s, 1 T34, 1 U79, 21 foundation grants, 4 awards from
the Sackler Institute of Developmental Psychobiology, 4 NIH loan repayment awards, and 1 award from the New
York State Office of Mental Health. In addition, 3 K award applications are under review from current fellows or
very recent graduates. Of the 46 trainees who have completed our T32 in the past 14 years, 83% are now in
research positions. We currently have 6 fellows, with 1 graduating next month and 1 new MD fellow accepted to
begin July 2019.
In the last submission of this T32, the committee noted the high rate of success amongst past trainees who
have largely gone on to secure academic positions and who have demonstrated strong track records of
publishing and obtaining extramural funding. The committee also noted our “outstanding group of mentors who
represent broad interdisciplinary expertise” and our “well-outlined training curriculum that strongly incorporates
RDoC, and the excellent pool of applicants.” Herein, we take steps to further improve our successful training
program and our recruitment of a diverse applicant pool and, specifically, physician scientists. We include
explicit processes for mentoring our mentors and now emphasize training in data science and computational
psychiatry methods, while continuing to offer innovative training in translational neuroscience.

Public health relevance
We urgently need to sustain and grow training opportunities to address the critical shortage of investigators who are prepared to transform child mental health with our growing understanding of neurobiology. The Translational Research Training in Child Psychiatry Program at Columbia University/New York State Psychiatric Institute is designed to address this shortage by increasing the cadre of clinician-scientists and clinically-informed neuroscientists trained to undertake translational research in child and adolescent mental health.